BCNU PLUS IV HYDROXYUREA FOR ANAPLASTIC GLIOMAS

This study will determine toxicity and maximum tolerated dose of hydroxyurea given concurrently with standard BCNU in anaplastic gliomas and estimate response rate to this regimen. Separate dose-escalation cohorts are accrued for newly diagnosed tumors (pre-radiation) and recurrent tumors following radiotherapy.